BRAINedu: A Window into the Brain/Una Ventana al Cerebro; Providing Hispanic students and families with bilingual resources about brain structure and function, neuroscience careers, and mental health.

BRAINedu: A Window into the Brain/Una Ventana al Cerebro Project Abstract – Twin Cities PBS BRAINedu: A Window into the Brain/Una Ventana al Cerebro is a national Spanish/English informal education project providing culturally competent programming and media resources about the brain’s structure and function to Hispanic middle school students and their families. The project responds to the need to eliminate proven barriers to Hispanic students’ STEM/neuroscience education, increase Hispanic participation in neuroscience and mental health careers and increase Hispanic utilization of mental health resources. The program’s goals are to engage Hispanic learners and families by 1) empowering informal STEM educators to provide culturally competent activities about the brain’s structure and function; 2) demonstrating neuroscience and mental health career options; and 3) reducing mental health stigma, thus increasing help-seeking behavior. The hypothesis underpinning BRAINedu’s four-year project plan is that participating Hispanic youth and families will be able to explain how the brain works and describe specific brain disorders; demonstrate a higher level of interest of neuroscience and mental health careers and be more willing to openly discuss and seek support for brain disorders and mental health conditions. To achieve program goals, Twin Cities PBS (TPT) will leverage existing partnerships with Hispanic- serving youth educational organizations to provide culturally competent learning opportunities about brain health to Hispanic students and families. TPT will partner with neuroscience and mental health professionals, cultural competency experts and Hispanic-serving informal STEM educators to complete the following objectives: 1) Develop bilingual educational resources for multigenerational audiences; 2) Provide professional development around neuroscience education to informal educators, empowering them to implement programming with Hispanic youth and families, and 3) Develop role model video profiles of Hispanic neuroscience professionals, and help partner organizations produce autobiographical student videos. We will employ rigorous evaluation strategies to measure the project’s impact on Hispanic participants’: a) understanding of neuroscience and brain health, particularly around disorders that disproportionately affect the Hispanic community; b) motivation to pursue neuroscience or mental health career paths; and c) mental health literacy and help-seeking behavior. The project will directly reach 72 Hispanic-serving informal STEM educators and public health professionals, and 200 children and 400 parents in underserved urban, suburban and rural communities nationwide.

Public health relevance
BRAINedu: A Window into the Brain/Una Ventana al Cerebro Project Narrative – Twin Cities PBS BRAINedu: A Window into the Brain/Una Ventana al Cerebro will provide culturally competent Spanish/English educational programming and digital resources to Hispanic middle school students and their families in underserved communities via existing youth-serving informal STEM engagement programs nationwide to 1) illuminate current research around structure and function of the healthy and unhealthy brain, including disorders such as Alzheimer’s, depression and epilepsy; 2) encourage Hispanic youth and their families to consider careers in neuroscience and/or brain health; and 3) promote mental health literacy among Hispanic participants. The resources developed through this initiative, including bilingual (Spanish/English) educational activities; professional development workshops for Hispanic- serving informal STEM educators and bilingual digital media assets, will be validated by neuroscience/mental health and cultural competency experts, field-tested, refined, and independently evaluated regarding their effectiveness. Ultimately, our anticipated outcomes are that participating Hispanic youth and families will demonstrate a higher level of interest of neuroscience careers; be able to explain how the brain works and describe specific brain disorders; and be more willing to openly discuss and seek support for brain disorders and mental health conditions.